Impact of the COVID-19 Pandemic on Help Seeking of American Indian and Black Women Experiencing Intimate Partner Violence

ABSTRACT
Intimate partner violence (IPV) is a complex and pervasive public health problem disproportionately affecting
American Indian (AI) and Black women, who ordinarily do not seek help, but who experience the worst health
outcomes including homicide. With the ongoing COVID-19 pandemic, help-seeking for AI and Black women has
become even more complicated amidst a global concern among advocates that social distancing, quarantine,
and isolation measures are inadvertently endangering women experiencing IPV. To our knowledge, while
anecdotal evidence shows that the COVID-19 pandemic has complicated women’s experiences of violence with
a possible rise in levels of violence resulting in lethal outcomes, no systematic studies exist that track women’s
experiences of IPV during this pandemic. To address this urgent gap, we propose a community-based
participatory research (CBPR) study informed by Indigenous and Black feminist thought, that will employ
qualitative and quantitative methods, enabling us to systematically describe the unique and intersecting
structural, economic, and interpersonal facilitators and barriers to help-seeking for IPV among AI and Black
women in urban and rural areas of Wisconsin during theCOVID-19 pandemic. We will conduct surveys and
individual and focus group interviews with 300 AI and Black women every year for three years to track women’s
experiences, patterns of help-seeking, and barriers to help-seeking. Women will be recruited from community-
based partner agencies across the state as well as at other sites where our partners ordinarily inform women
about their services, in order to capture women seeking help as well as women who have not sought help. Our
ultimate goal through this study is to create a platform where women’s voices can then inform health practice
and health policy while also drawing from a community advisory board constituted of advocates and other key
members of AI and Black communities in Wisconsin, to provide actionable recommendations for addressing the
urgent problem of IPV in the lives of AI and Black women. Our proposed CBPR study is in line with the mission
and goals of the National Institute on Minority Health and Health Disparities because it focuses on two
populations that are disproportionately affected by the pandemic, while also ordinarily disproportionately
impacted by IPV. Additionally, this CBPR study engages grassroots, community-based agencies with an
academic partner (University of Wisconsin-Milwaukee) in scholarship that is grounded in women’s realities, is
participatory in nature, and is built upon the capacities and the resilience of community members.

Public health relevance
Intimate partner violence (IPV) is considered a public health problem in the United States, with many scholars identifying it as a public health crisis. American Indian (AI) and Black women in the United States are disproportionately affected by IPV with the communities in which they live also currently disproportionately affected by the COVID-19 pandemic. It is an urgent matter of public health that we systematically identify, in an effort to minimize, the barriers to help- seeking for IPV that AI and Black women are experiencing during the pandemic, in order to inform policy and improve health outcomes for AI and Black populations of women.